EVALUATIONS OF PROSTHETIC CARDIAC VALVES--IN VIVO STUDIES

The studies of this project are those of the ongoing use of juvenile sheep for evaluating cardiac valve pathology and pathophysiology. Previous years' studies have concentrated upon conventional hydraulic/hemodynamic evaluations of native and prosthetic cardiac valves, and upon the morphologic and physical characterization of calcific degeneration of bioprosthetic valves. Efforts during the current year explored the following areas: (1) studies of homograft mitral valve substitutes; and (2) studies of Doppler determined intracardiac flow dynamics. The first studies have demonstrated the feasibility of homograft mitral valve replacement, providing a unique mode for investigating mechanisms of bioprosthetic valve leaflet degeneration and mineralization. The current studies have added credence to the hypothesis that preimplantation glutaraldehyde treatment facilitates mineralization. Two-dimensional, color-encoded Doppler evaluations of intracardiac flow dynamics using fundamental physical theories of jet flux and momentum continuity preservation have provided quantitative volumetric information regarding valvular regurgitation.